Fluorescence guided surgery using near infrared nerve-specific probes for cranial nerve preservation

PROJECT SUMMARY
Iatrogenic nerve injury represents one of the most feared surgical complications. Nerves are critically important
to the function of most tissues and nerve injury can lead to permanent disability. Surgery is performed commonly
in the U.S. with approximately 40 million operations annually, incurring up to 600,000 iatrogenic nerve injuries.
Essential nerves may be injured across surgical specialties including general, thoracic, cardiac, urologic, plastic,
colorectal, spinal, neuro-, otolaryngologic and orthopaedic surgery. Surprisingly, no clinically approved technol-
ogy can directly enhance intraoperative nerve visualization, which is typically performed through neuroanatomi-
cal knowledge, conventional white light imaging and electrophysiologic monitoring. This work will directly address
this unmet clinical need. Fluorescence guided surgery (FGS) is a form of surgical guidance that seeks to improve
the safety and efficacy of surgery through machine-assisted visual identification of critical tissues that require
removal (e.g., tumors) or structures that must be preserved to maintain post-operative function (e.g., nerves).
Clinical open and laparoscopic FGS vision systems operate nearly exclusively in the near infrared (NIR, 650-
900 nm). To employ FGS, clinicians typically administer a fluorescent contrast agent intravenously (IV) prior to
surgery that accumulates or marks tissues of interest (e.g., blood vessels, tumors, etc.) and deploy intraoperative
FGS vision systems capable of imaging the contrast agent distribution in the surgical field in real time. While
novel contrast agents for surgery are under development with the first molecularly targeted agent (i.e., pafola-
cianine) reaching recent FDA approval, clinical adoption and routine use for surgery remain an open question.
Part of this challenge stems from the integration of administration of the contrast agent into the existing clinical
workflow. Most of the developed targeted contrast agents require IV administration, presenting specific chal-
lenges to integration into the existing surgical workflow. IV administration of probes requires either a special trip
and appointment to the hospital or surgical center or a substantially earlier start time to accommodate the phar-
macokinetic (PK) profile of the probe. For patients that live in a rural setting, requiring long distance travel to their
surgical center or critically ill patients, this creates hardships and further challenges to availability of care. For
surgical centers and hospitals that are already straining to keep up with the workload, the IV contrast administra-
tion requires additional time and costs to integrate FGS into the clinical workflow. To alleviate these challenges,
we will explore additional routes for nerve contrast agent administration, including orally and subcutaneously
using agents with long pharmacokinetic profiles. Our overall vision for this technological advance is that nerve-
specific contrast could be administered at home, decreasing the burden on patients and the health care system
while still permitting identification and visualization of nerve-specific contrast during surgery.

Public health relevance
PROJECT NARRATIVE Iatrogenic surgical nerve injury continues to challenge even experienced surgeons, leaving patients with pain, loss of function and decreased quality of life. Our team has developed novel nerve-specific contrast agents to improve nerve identification and visualization in the surgical suite. Herein, we will investigate the utility of alternant administration routes to make integration into the clinical workflow seamless.